Glycobiology Core

and the other cores, and will coordinate, direct, and monitor the synthesis of human milk glycans executed in Cincinnati, Mexico,and Boston. PHS 398/2590 (Rev. 11/07) Page 345 Continuation Format Page Massachusetts General Hospital Core C Program Director/Principal Investigator (Last, First, Middle): Morrow, Ardythe, L. (also